Cannabinoids as an environmental risk factor of testicular cancer: Assessment using cell culture models of human and mouse primordial germ cells and by exposure of pregnant mice

1 Testicular cancer (TC) is the most common malignancy among young men aged 15 to 44 in the Unites States
2 and many other countries. Whereas TC has strong genetic risk factors such as race or family history, the
3 recent and global increase in TC incidence rate suggests the importance of the environmental risk factors in
4 TC etiology. Multiple epidemiological studies independently found a significant link between marijuana use and
5 increase in the TC risk. TC is derived from embryonic germline precursor cells – namely, primordial germ cells
6 (PGCs) or gonocytes, and its tumorigenesis initiates prenatally to form pre-malignant precursor lesions known
7 as Germ Cell Neoplasia In Situ (GCNIS) in testes before birth although diagnosis of TC peaks 25-35 years
8 after birth. Because all available studies link the increased TC risk to adolescence/adult marijuana use, critical
9 knowledge on effects of prenatal exposure to marijuana on TC risk is missing. The endocannabinoid system
10 regulates development of mammalian germ cells via paracrine actions through the cannabinoid receptors CB1
11 and/or CB2 expressed in germ cells and/or testicular somatic cells. We therefore hypothesize that the major
12 marijuana cannabinoids D9-tetrahydrocannabinol (THC) and/or cannabidiol (CBD) may disrupt the normal
13 development of male PGCs/gonocytes via the cannabinoid receptors expressed by these germ cells and/or the
14 testicular somatic cells, leading to germ cell maldevelopment and transformation. To test this hypothesis, our
15 Specific Aim 1 will use human PGC-Like Cells (PGCLCs), a pluripotent stem-cell derived cell culture model of
16 PGCs, and the xenogeneic reconstituted testis (xrTestis), an organoid culture model in which human PGCLCs
17 are supported by mouse embryonic testicular somatic cells and differentiate to gonocyte-like cells (GoLCs). We
18 will expose normal or TC patient-derived PGCLCs (which harbor the genetic TC risk) with or without CRISPR-
19 knockout of CB1 and/or CB2, or xrTestes involving these PGCLCs, to THC, CBD, endocannabinoids, and
20 selective agonists/antagonists of the two cannabinoid receptors followed by bulk/single-cell deep sequencing
21 and various standard assays to obtain evidence that exposure of PGCLCs/xrTestis to cannabinoids causes
22 germ cell responses relevant to transformation, such as enhanced growth, delayed mitotic arrest of GoLCs,
23 suppression of apoptosis, chromosomal aneuploidy, and/or impaired differentiation. To distinguish the whole-
24 body effects of marijuana and its direct actions on prenatal testes, Specific Aim 2 will expose timed-pregnant
25 mice to THC and CBD during 12.5-17.5 dpc and collect fetal testes. Organ cultures of E12.5 embryonic testes
26 will also be exposed to THC and CBD for 5 days in vitro. Testicular samples after the in vivo or ex vivo
27 exposure to marijuana cannabinoids will be subjected to assays as described for Specific Aim 1 to obtain
28 evidence of germ cell transformation. The proposed research may obtain mechanistic evidence supporting the
29 link between marijuana and TC risk via direct gonadal effects of the cannabinoids, urging epidemiological
30 studies on marijuana use by pregnant women and TC risk of their male children.

Public health relevance
Whereas many states in the United States have completed, or are currently moving toward, legalizing or decriminalizing consumption of marijuana as a recreational drug, epidemiological studies have been accumulating evidence that exposure to marijuana may be linked to increased risk of testicular cancer. Pre- cancerous lesion of this type of malignancy is formed by immature and abnormally developed germ cells in fetal testes before birth; but no experimental studies involving analyses of human or animal germ cells after exposure to the marijuana cannabinoids in the context of testicular cancer risk have been performed so far, leaving critical knowledge gap to understand the potential threats posed by this rapidly prevailing habit of drug consumption. Taking advantage of the cutting-edge techniques to create cells and organoids resembling human germ cells in embryonic testes as well organ culture method of embryonic mouse testes, this project will determine whether marijuana cannabinoids have biological potential to deviate human and/or mouse germ cells from their normal developmental path and thus increase the risk of testicular cancer.